Genomic approaches to understand human neural specializations

PROJECT SUMMARY/ABSTRACT
Humans have evolved an expanded and elaborated brain capable of higher-order cognition. However, the
sequence variants and resulting neural specializations that distinguish humans from other mammals are
commonly dysregulated in diseases such as autism spectrum disorder (ASD). This suggests that human-specific
non-coding variants are enriched for neural functions and may underlie genetic and phenotypic disease
vulnerabilities. Thus, there is a critical need to identify and characterize the non-coding variants that underlie
human neural specializations. However, identifying the causal variants that contribute to human neural
specializations is a daunting challenge that has been likened to searching for needles in a haystack. In this
proposal, Dr. Janet Song will improve prioritization of human-specific variants for further functional analysis using
two complementary approaches (Aims 1 and 2) and determine whether prioritized variants regulate nearby gene
expression in a high-throughput manner (Aim 3). Dr. Song will use the human-chimpanzee tetraploid system to
link regulatory regions that are differentially accessible between species to nearby differential genes in neural
progenitor cells and excitatory neurons, two cell types that are profoundly changed in humans and are commonly
dysregulated in neurological diseases (Aim 1 – K99 phase). As a complementary approach, Dr. Song will identify
constrained human-specific insertions and assess their contribution to ASD risk (Aim 2 – K99/R00 phase). Dr.
Song will then evaluate the effects of human-specific variants on nearby gene expression in neural cell types
using CRISPR inhibition screens (Aim 3 – K99/R00 phase).
This K99/R00 proposal will support Dr. Janet Song in her pursuit of the genetic basis of human neural
specializations and allow her to acquire new skills in comparative and functional genomics that will open up
innovative approaches to explore this problem. This proposal will be initiated during the mentored period in Dr.
Christopher Walsh’s lab at Boston Children’s Hospital / Harvard Medical School and continue in Dr. Song’s own
lab upon securing an independent position. In addition to providing immediate insights into the genetic basis of
human neural specializations, the proposed research will lay the foundation for Dr. Song’s independent research
program. It will provide a framework for future studies in additional cell types or paradigms, pinpoint high-priority
loci for single-locus studies, and identify a corpus of human-evolved elements that may contribute to genetic risk
for neurodevelopmental and neuropsychiatric diseases. Long-term, Dr. Song’s independent research program
will dissect how sequences that changed in humans relative to other mammals result in human-specific neural
phenotypes, and ultimately, contribute to neurodevelopmental and neuropsychiatric diseases.

Public health relevance
PROJECT NARRATIVE Genetic variants between humans and other mammals underlie the unique cognitive features that have evolved in the human lineage. Unfortunately, these variants and their resulting human neural specializations are also commonly dysregulated in diseases such as autism spectrum disorder. To identify and characterize genetic variants that underlie human cognition and may be mutated in neurological diseases, this study will use the human-chimpanzee tetraploid system and comparative genomics to prioritize variants for functional study, and evaluate variants in CRISPR inhibition screens in a high-throughput manner.